Studying the role of skin pathobionts in Cutaneous T cell Lymphoma

PROJECT SUMMARY
Cutaneous T cell lymphoma (CTCL) involves dermal expansion and accumulation of malignant CD4+ T cells.
While putative triggers ranging from chemical exposures to microbial elements have been suggested, the
etiology of CTCL is unknown. However, studies have observed increased skin colonization with S. aureus in
CTCL patients compared to healthy controls, and a small trial documented disease regression in response to
aggressive antibiotic treatment that eradicated S. aureus colonization.
These findings suggest that S. aureus colonization may play a role in the progression of CTCL, although no
unifying mechanism for this relationship has been uncovered to date. There are major gaps in our knowledge,
which will be addressed by the experiments in this proposal:
1) Is S. aureus indeed enriched in CTCL patient skin microbiomes, and what strain(s) and virulence
factor(s) are found in patient samples? And how does the presence of S. aureus impact malignant cell
features in CTCL patient samples?
2) Is S. aureus contributing to CTCL progression in vivo?
3) And is in vivo CTCL progression mediated by an antigen-specific response in the skin?
Prior studies have been limited by low patient numbers, as CTCL is a rare disease, and a lack of
comprehensive integration of 16S sequencing, microbial molecular genetics, and malignant cell characteristics.
This study will overcome these limitations through sample collection of over 200 CTCL patients for analysis,
including 102 previously collected samples from collaborating clinicians, and an additional 100 CTCL samples
to be collected through our active, IRB-approved human studies spanning multiple institutions. Microbial
analysis will reveal the proportions of, and genetic characteristics of, S. aureus in the CTCL microbiome, and
the relationship between the skin microbiome and human malignant T cell activation, as determined by single-
cell surface expression and transcriptomics (Aim 1). In vivo mouse models of CTCL subjected to S. aureus
colonization will allow study of skin-resident immune responses to S. aureus, and its mechanistic relationship
to disease progression (Aim 2). And finally, sophisticated in vivo models of CTCL will be used to determine if
topical antigenic stimulation is sufficient and necessary to drive disease progression in the skin (Aim 3).

Public health relevance
PROJECT NARRATIVE Despite progress in its clinical management, Cutaneous T cell Lymphoma (CTCL) still causes a high level of morbidity for patients, and targeted therapeutics are limited because disease-inciting factors are largely unknown. Using a combination of patient samples and in vivo mouse model experiments, this work will determine if the dysbiotic, S. aureus-enriched skin microbiome observed in CTCL patients contributes to disease progression and morbidity through a potential mechanism involving TCR signaling and T cell activation. This research will contribute fundamental knowledge about the role of the skin microbiome in CTCL disease progression and has the potential to fully elucidate dysbiotic microbiome states which could be targeted by anti- microbial therapeutics to enhance health and reduce morbidity in CTCL patients.